Immunomodulatory impact of the gut microbiome on tumor progression

Project Summary
The human gut microbiome is comprised of bacteria and other microorganisms that inhabit the gastrointestinal
tract and play a pivotal role in host health. Recent studies have shown the contributing role of the gut microbiome
to outcomes of immunotherapy, specifically immune checkpoint inhibition. In a promising phase I clinical trial,
fecal microbiome transplantation from a patient that is responsive to immune checkpoint inhibition into
immunotherapy resistant patients improved their responsiveness to treatment. This novel approach for cancer
therapy highlights the potential of therapies that can target the immunomodulatory role of the gut microbiome on
the host. Despite early clinical success, we still lack the understanding of the underlying mechanisms driving
these microbiome effects. Therefore, the goal of this project is to investigate the mechanisms behind the
immunomodulatory role of the gut microbiome in cancer by looking at effector molecules produced by the gut
microbiome and their bioactivities. The hypothesis driving this work is that the gut microbiome produces bioactive
molecules that slow down tumor progression by modulating the host immune system. Preliminary results in a
mouse model of melanoma wherein germ-free mice were colonized with six healthy human gut microbiomes
shows substantial variability in baseline tumor growth independently from immunotherapy. In preliminary immune
characterization, donor microbiome-colonized mice with the slowest tumor progression show increased
frequency of interferon gamma expressing cytotoxic T cells in tumor-infiltrating lymphocytes. I designed a study
that combines two complimentary aims that utilize host-centric and microbiome-centric approaches. Aim 1 will
characterize immune cell populations altered by the gut microbiome during tumor progression. In tumor bearing
mice harboring human gut microbiomes, I will profile systematic and tumor-specific immune changes and
quantify the expression of immune cell activation and exhaustion markers. Aim 2 will identify gut microbiome-
derived bacterial products that impact tumor-immune crosstalk. I will utilize cellular assays that probe tumor-
immune cell interactions to test: (a) bacterial strains enriched in patient cohorts that underwent immunotherapy,
(b) small molecules produced by ex vivo cultures of donor microbiomes, (c) bacterial metabolites from donor-
colonized mice. Completion of the proposed work will provide a foundation to develop innovative microbiome
targeted adjuvant therapies for cancer patients. By utilizing the combined expertise of two leading labs in the
fields of cancer molecular biology and host-microbiome interactions, this study will provide novel insights into
the crosstalk between the tumor cells, immune cells, and the gut microbiome. Through the Rutgers Robert Wood
Johnson Medical School and Princeton University MD/PhD program, I will learn cutting-edge techniques in
cancer research, develop my academic communication skills, form a network of scientist and clinician mentors,
and integrate my research and clinical training. My personalized professional development plan sets me on the
right track to enter a research track residency and become an independent physician scientist.

Public health relevance
Project Narrative Despite the gut microbiome’s therapeutic promise for clinical intervention in cancer patients, we have yet to develop a complete understanding of the mechanisms behind its effect on cancer. The project objective is to map the connections from microbiome-derived molecules to host immune cells and their resulting impact on tumor dynamics. Identifying bioactive molecules produced by the gut microbiome that slow down tumor progression will allow us to create targeted therapies to improve tumor outcomes.